Leveraging artificial intelligence/machine learning-based technology to overcome specialized training and technology barriers for the diagnosis and prognostication of colorectal cancer in Africa

SUMMARY/ABSTRACT
Colorectal cancer (CRC) is the third most commonly diagnosed cancer and the second leading cause of
cancer related deaths worldwide. Rates in Africa are on the rise, but essential histopathology services critical
for cancer care are scarce. To address this barrier, we developed an artificial intelligence (AI)/machine learning
(ML)-based computational pipeline (SIVQ/VIPR) that performs automated pixel-level image segmentation and
classification from digital images of routinely collected hematoxylin and eosin (H&E)-stained slides. SIVQ/VIPR
is highly precise, reproducible, and outperforms subject matter experts. Once histologically distinct regions are
identified, image analysis algorithms can then identify individual regions and aggregate them to predict
diagnostic and prognostic features in conjunction with clinical outcomes to guide treatment. Our overall
approach is to leverage our validated SIVQ/VIPR computational pipeline to develop and validate an AI-based
diagnostic decision support (AI-DDS) tool for CRC diagnosis and prognosis in an existing Kenyan cohort. To
carry out this work, the Aga Khan University (AKU)- East Africa and the University of Michigan have partnered
with Tenwek Hospital, a non-academic community-based public hospital in rural Bomet, Kenya, to develop a
unique collaboration of oncologists, pathologists, surgeons, statisticians, and informaticians, making us
uniquely suited to develop population-relevant, affordable, and scalable data science solutions in Kenya – all
priorities of the DS-I Africa Program. We will: Aim 1. Adapt and validate an existing ML-based diagnostic
algorithm for CRC using digital fields of view from H&E-stained slides in a retrospective cohort of n=675 CRC
cases from the AKU and Tenwek Hospitals. We will apply the CRC-trained SIVQ/VIPR computational pipeline
for segmentation and classification for CRC features, followed by a confirmatory classifier step to achieve a
case level, binary result of a cancer/no-cancer (i.e., diagnosis). Aim 2. Develop and refine an unsupervised ML
method to identify histopathology image-derived measurements associated with CRC
prognosis.
We will use
computer/machine vision approaches to identify image features (e.g., cellular morphology) discriminative of
CRC prognosis and biological potential for disease aggressiveness. Combined use of AI-based morphological
signatures of aggressive disease (e.g., high-grade tumor architecture) will be compiled with other clinically
relevant features towards the goal of generating a multi-axial multiplexed AI-DDS tool that can maximally
inform of the biological and metastatic potential of each CRC case. This project will lay the groundwork for an
AI-DDS tool for clinicians (e.g., pathologists, oncologists) that facilitates prompt and accurate diagnosis,
prognosis, and risk stratification for CRC care in Africa. Because this approach leverages open-source
software and can be deployed as a turn-key system intended for web-based cloud deployment, it is well-suited
for capacity building, integrating into educational programs, and expanding to other emergent or prevalent
cancers (i.e., breast, cervical, prostate) as part of the DS-I Africa Consortium.

Public health relevance
NARRATIVE To overcome existing barriers to histopathology services critical for cancer care in Africa, this project aims to leverage an existing artificial intelligence (AI)/machine learning-based computational pipeline to develop and validate image analysis algorithms for colorectal cancer (CRC) diagnosis and prognosis in an existing Kenyan cohort. This project will lay the groundwork for an AI-enabled decision support tool for pathologists, or other clinicians involved in cancer care (i.e., radiation oncologist, oncologist), to facilitate prompt and accurate diagnosis, prognosis, risk stratification, and thus therapeutic selection for CRC. Because the computational pipeline leverages open-source software and can be implemented as a turn-key solution intended for web- based cloud deployment, it is well-suited for clinical delivery, capacity building and integration into educational programs, and for future expansion to other emergent or prevalent cancers (i.e., breast, cervical, prostate) in Africa as part of the DS-I Africa Consortium.